Pharmacogenomic approaches to drug metabolism in American Indian/Alaska Native People

Project Summary/Abstract
With the establishment of many large biobanks and consortia, and calls for increasing the diversity in
participants, it is imperative to develop robust evidence-based approaches to support the engagement of
diverse participants and to develop a proper bioethics-informed framework. The parent grant, entitled
“Pharmacogenomic approaches to drug metabolism in American Indian/Alaska Native (AIAN) People”, strives
to increase diversity in genomics research by developing a general model for research that engages all
communities. In this supplement, we enhance the ability to achieve this goal by recruiting members of
historically underrepresented communities to share perspectives on important bioethical issues related to
participant engagement, return of results, and data sharing. We will identify these individuals by recontacting
participants enrolled in the Colorado Center for Personalized Medicine (CCPM) Biobank research study at the
University of Colorado Anschutz Medical Campus, who have already consented to participate in genomics
research. Using mixed-methods and community-based participatory research frameworks, we aim to: 1)
Understand perspectives on participant engagement, return of results, and data sharing from historically
underrepresented participants (e.g., AIAN, African American, and Hispanic/Latino) in the CCPM Biobank with
focus groups and surveys; and 2) Develop a cross-site framework for assessing biobank participants
perspectives and engagement related to bioethical issues in biomedical research. The inclusion of African
American and Hispanic/Latino participants, in addition to AIAN communities, aligns with the parent grant goal
to equitably engage and build capacity for diverse communities. The CCPM Biobank offers an ideal population
for these activities, given its diverse and growing population, unique infrastructure that allows for quick
participant recontact, and successful reengagement with participants for research in recent years. Ultimately,
these evidence-building efforts are essential for the broader scientific community to develop culturally
informed, bioethical policies and frameworks around participant engagement, return of genomics research
results, and data sharing.

Public health relevance
Project Narrative This work will involve developing and deepening partnerships with underrepresented populations, as a necessary foundation for doing the transformative work to produce a general model for research that engages all communities involved in or considering being involved in genomic research. In addition, we will expand the involvement of diverse populations in genomic research and build capacity among American Indian and Alaska Native communities.